Impact of BTEX Chemical Exposure During Pregnancy to Maternal and Fetal Well-Being

Abstract
Among the 100 American cities with the greatest number of births, Detroit has the highest reported preterm birth
(PTB) rate of 15.2%.1 The etiologic factors that play central roles in this public health emergency are currently
unknown. However, evidence suggests that exposure to volatile, very volatile, and semi-volatile organic
compounds (collectively abbreviated VOCs) during vulnerable life windows of susceptibility is an important
determinant of maternal-offspring health, with implications for PTB and associated adverse health outcomes.
The Center for Leadership in Environmental Awareness and Research (CLEAR) is dedicated to understanding
and mitigating this serious environmental health problem. The central theme of Project B2 focuses on
deciphering the signaling pathways by which exposure to VOCs during pregnancy have an impact on early life
growth and development with a focus on the fetal immune system. Our central hypothesis is that inflammation
in the placenta and decidua due to maternal exposure to VOCs, alters the development of the fetal
immune system, which results in an aberrant post-natal immune response to infections. Our preliminary
studies suggest that although the fetus may be protected against microbial infection, the outcome of maternal
exposure, protective or deleterious, depends on the nature of the immune response and the severity of the
inflammatory process at the implantation site (placenta-decidua interface). The mechanisms underlying the
response of the fetal immune system to VOC exposure and how indirect training by VOC-induced maternal
inflammation takes place is unclear and understudied. Our specific aims are:
Aim 1. To determine the effect of BTEX maternal exposure on placental and fetal inflammation.
Aim 2. To determine the impact of VOCs exposure on TLR signaling responsible for the homing and
differentiation of T and B cells.
Aim 3. Characterize the offspring immune responses of pups from mothers with VOCs exposure to
microbial infection.
Upon completion of these aims we will have a better understanding of the outcomes associated with the impact
of VOCs exposure on the placental/decidua unit and its consequent influence on fetal programing and its
potential effects on the development of an appropriate neonatal immune responses. B2 is a mechanistic bridge
between the zebrafish (B1) and epidemiological (B3) projects that utilizes a placental model of inhalational VOC
exposure. The Chemical Analysis Core will quantitate BTEX metabolites and the Data Management and Analysis
Core will disseminate data among the biomedical projects to make comparisons between fish, mouse, and
human exposures paradigms possible. B2 will inform future epidemiological studies that investigate associations
between maternal VOC exposures and inflammatory outcomes in children such as asthma.

Public health relevance
Project Narrative The Center for Leadership in Environmental Awareness and Research (CLEAR) has built an integrated, transdisciplinary framework, rooted in advanced techniques in environmental engineering and biomedical research, to address human exposures to volatile organic compounds (VOCs) and health risks in urban areas. Research findings on (a) the relationship between VOC exposure and human health risks—for preterm birth and related health outcomes in particular—combined with (b) new methods and technologies to assess and reduce those health risks, and (c) a new understanding of related biological systems, will contribute to improved public health interventions. CLEAR research is expected to have a direct impact on affected communities, stakeholders, and the agencies responsible for Superfund site management and the reduction of environmental VOC exposure. Project B2 uses a mouse model to decipher the signaling pathways by which exposure to VOCs during pregnancy have an impact on early life growth and development with a particular focus on the developing fetal immune system.